Imaging, Protein Production, and Chemical Biology Core

Core A: Imaging, Protein Production, and Chemical Biology Core
SUMMARY/ABSTRACT
The goal of the Imaging, Protein Production, and Chemical Biology Core is to maximize the scientific progress
and productivity of PPG investigators by providing essential services and reagents. The core will perform three
major functions for the PPG: (1) advanced light and electron microscopy imaging;; (2) protein and antibody
production;; and (3) chemical proteomics. All three PPG component projects will utilize at least two core services,
and two of the projects will utilize all three. Centralizing these activities within a core will benefit the PPG by
increasing productivity and reducing costs. The core will provide full-­service scanning and transmission electron
microscopy, standard and live-­cell confocal fluorescence microscopy, and NanoSIMS imaging. The latter is a
mass spectrometry–based imaging modality that makes it possible to create high-­resolution images of cells and
tissues based solely on their isotopic content. PPG investigators will use NanoSIMS to visualize and quantify the
localization and movement of lipids in cells and tissues. PPG investigators will also study new molecules and
novel mechanisms regulating lipid transport and signaling, for which few reagents exist. To assist these
investigations, the core will produce protein and antibody reagents for PPG studies (e.g., soluble GPIHBP1,
stable isotope–labeled ALO-­D4, 5D2 Fab fragments). Finally, the core will perform Activity-­Based Chemical
Proteomics and isotopic Tandem Orthogonal Proteolysis‒Activity-­Based Protein Profiling. These state-­of-­the-­art
proteomics discovery platforms will be used to identify proteins involved in the intracellular trafficking of HDL-­
derived cholesterol and the regulation of STING signaling by cholesterol. For the next five years, the core is
poised—with the experience, robust protocols, and experienced personnel—to provide vital services to PPG
investigators.